A Portable, Liquid-Helium-Free 1-T/560-mm RT bore Point-of-Care MRI Magnet: Prototype Demonstration

Project Summary
Magnetic resonance imaging (MRI) is a widely used medical diagnostic tool. Nearly 50% of MR scans
are of the head to diagnose ailments, injuries, and diseases including: 1) stroke; 2) other cerebrovascular
conditions (e.g., aneurysm and atherosclerosis); 3) brain injury (concussion, TBI, hematoma); 4) tumors;
5) neurodegenerative disorders (e.g., multiple sclerosis, Alzheimer’s, epilepsy; 6) headache; 7) infections
(e.g., meningitis). Standard MRI scanners, installed in special MRI rooms, operate with fields of ≥1.5 T.
However, <<1 T scanners have been finding some niche applications in bedside and intrasurgical and
interventional situations. Although some of these scanners are compact, and may be “portable,” they
have a serious limitation of relying on permanent magnets and therefore suffer from low image quality.
For example, Hyperfine, with the 0.064-T permanent magnet, markets a portable MRI system for patients
in the hospital bed, which allows for critical decision-making in some clinical settings, but its images would
never be considered to be of general diagnostic quality. In this project we introduce, for the first time, a
portable superconducting 1.0-T head-dedicated MRI magnet, a field that yields proven diagnostic image
quality. With the proposed innovative magnet technology incorporated, we believe that this
superconducting head MRI will revolutionize point-of-care diagnostics, e.g., in triaging traumatic brain
and other injuries at sports events, concerts, disasters, battlefields, and Hospital at Home. The speciﬁc
aim of this 5-year project is to develop and demonstrate a portable head-imaging MRI magnet system.
During operation, our proposed MgB2 superconducting 1.0 T magnet will be free from an external power
supply and a refrigeration system. We will use off-the-shelf devices in a separate rack for MRI electronics;
and use a custom designed head gradient coil cooled by a closed-loop water-to-air heat exchanger to
dispense with a power-consuming water chiller. For our proposed portable 1.0-T MRI unit, we plan to use
a detachable “cryocirculator” that circulates cold working fluid, and most importantly for portability, that
can be readily coupled to or decoupled from the magnet system, in contrast to a conventional cryocooler
that is mechanically attached to the magnet system. Another unique feature of our system is a volume of
solid cryogen, e.g. solid neon, in the cold chamber that adds enough thermal mass to the magnet,
enabling it to maintain its field over a period of, for this system, ≥8 hours, plenty enough for this portable
MRI system, uncoupled from its cryocirculator, to perform its mission before it needs recooling.

Public health relevance
Narrative This project pioneers a novel MRI superconducting magnet technology that promises unprecedented portability, stronger magnetic field than conventional permanent magnet-based portable systems, and true diagnostic image quality, while completely eliminating the use of scarce and expensive liquid helium. The portable head MRI scanner, featuring this innovation, has the potential to revolutionize point-of-care diagnostics, including triaging traumatic brain and other injuries at sports events, concerts, disasters, battlefields, and Hospital at Home.